TRPA1 regulation of oral cancer nociception

Project summary
Oral cancer patients suffer persistent and severe pain at the primary site of the cancer. Oral cancer pain is
poorly managed with opioids. A small subset of cancer patients do not report pain. Oral cancer pain is initiated
and maintained in the tumor microenvironment (TME). Mediators released from the cancer sensitize primary
afferent neurons (nociceptors) and may also increase neuronal density in the TME to produce mechanical,
thermal and chemosensory hyperalgesia. Oral cancer patients report mechanical and functional allodynia, as
well as thermal and chemical hypersensitivity. These findings have been replicated in oral cancer mouse
models. Transient receptor potential (TRP) channels on neurons have been implicated in orofacial pain. TRP
vanilloid 1 (TRPV1) responds to acid and heat, but not mechanical stimuli. By contrast, TRP ankyrin repeat 1
(TRPA1), which is co-expressed with TRPV1 on a subset of nociceptors, has been implicated in mechanical
allodynia. Cancer pain is associated with increased density of nerves in the cancer microenvironment,
suggesting that increased TRPA1+ neuronal density in the TME of painful oral cancers mediates the
mechanical and functional allodynia experienced by patients. There is a gap in our knowledge, however,
regarding the neurobiological role of TRPA1 in mediation of oral cancer pain. The long-term goal is to define
the molecular anatomy of the oral cancer microenvironment, and the associated mechanisms that contribute to
oral cancer pain. The overall objectives of this application are to; 1) determine whether density of TRPA1+
fibers in the TME is greater in oral cancers from patients who report high levels of pain and 2) determine the
contribution of TRPA1 to mechanical allodynia and thermal hyperalgesia evoked by mediators released from
oral cancer cells in a mouse model of oral cancer pain. The central hypothesis is that oral cancer induced pain
(mechanical allodynia and thermal hyperalgesia) is mediated by sensitization of TRPA1 on sensory neurons.
The rationale for this project is that identification of specific receptors on sensory neurons sensitized by oral
cancer pain mediators provides the opportunity to develop novel therapies for oral cancer pain to reduce
dependence on opioids. The central hypothesis will be tested by pursuing two specific aims: 1) Evaluate
TRPA1 expression in a retrospective cohort of oral cancer patients with painful and non-painful cancers 2)
Evaluate the impact of TRPA1 on oral cancer nociception in a mouse model. Under the first aim TRPA1+
neuronal density in the TME will be measured in a retrospective patient cohort with highest and lowest pain
scores. For the second aim impact of TRPA1 on mechanical and thermal hypersensitivity will be measured in a
mouse model of oral cancer pain. The proposed research is innovative because the impact of TRPA1 on oral
cancer pain has not been studied. The proposed study is significant, because the results will determine
whether antagonism of the TRPA1-oral cancer axis could be beneficial in mitigation of oral cancer pain.

Public health relevance
Project Narrative Oral cancer patients suffer from severe, chronic pain. Mediators released from the cancer cells attract and sensitize nearby sensory nerves, resulting in increased density of nerves near the cancer and pain. This project seeks to better understand the types of neurons attracted to painful cancers, knowledge that can lead to new ways to relieve cancer pain.